Leveraging the seasonal malaria chemoprevention platform to address malaria and malnutrition

PROJECT SUMMARY/ABSTRACT
In the Sahel, the malaria and malnutrition seasons overlap during the rainy season, from approximately July
through October. Malaria transmission increases due to the rain and collection of standing water and
malnutrition risk increases because this period is the growing season, leading up to the annual harvest in
November. Seasonal malaria chemoprevention (SMC) is an antimalarial intervention that involves monthly
distribution of sulfadoxine-pyrimethamine (SP) and amodiaquine (AQ) to children aged 3-59 months during the
high malaria transmission season. SMC is distributed to millions of children annually in 13 countries in the
Sahel, including Burkina Faso. Although SMC distribution is highly effective against clinical malaria in children,
malaria remains a major cause of childhood mortality and morbidity in Burkina Faso. The SMC platform, which
involves monthly door-to-door delivery of SP-AQ, is an attractive platform for delivery of additional interventions
that may augment child health during this vulnerable season. Malaria and malnutrition co-occur in children and
communities, and interventions for one may affect the other. For example, previous work by our group and
others has shown that antimalarial treatments may improve weight gain in children with malnutrition. Here, we
propose a pilot trial designed to evaluate how the SMC platform may be leveraged to deliver co-interventions
with SMC that may augment its efficacy and reduce the incidence of malaria and malnutrition. We anticipate
that the results of this study will provide formative data for the development and implementation of a full-scale
study evaluating the effects of integration of nutritional interventions on the SMC platform. We anticipate that
such a strategy may provide optimal protection for children during the most vulnerable period of the year by
delivering interventions monthly on an existing platform that directly reaches millions of children each month.

Public health relevance
PROJECT NARRATIVE In the Sahel, the malaria and malnutrition seasons overlap, and may exacerbate one another. Here, we propose a pilot trial to understand how the SMC platform may be leveraged to co-deliver a nutritional intervention that may affect both malaria and malnutrition. We anticipate that the results of this study will provide evidence of co-interventions for malaria and malnutrition that will allow for the development and full- scale testing of future interventions targeted to children during particularly vulnerable periods.